Novel dermal templates for prevention and treatment of biofilms in cutaneous wounds

PROJECT SUMMARY
The goal of this Phase II SBIR proposal is to further develop an anti-bioﬁlm, peptide-based, tissue-
scaffolding matrix, G4B, for preventing and eliminating bioﬁlms from acute and chronic wounds.
Fifteen percent of the 347M diabetic patients worldwide will develop a foot ulcer1–3, of which 56% will
become infected4–6 and lead to chronic wounds. Approximately 60-78% of chronic wounds and 6%
of acute wounds contain microbial bioﬁlms 7,8. Bioﬁlms are a signiﬁcant cause of persistent
infections associated with prolonged inﬂammation, failure to re-epithelialize, and responsiveness to
wound management, all contributing to impaired and delayed wound healing7,10,11. Currently,
available wound care products show limited efficacy in promoting infection-free wound closure as
they: (i) lack effective antimicrobial agents, (ii) do not sufficiently promote healing, and (iii) semi-rigid
membrane sheets fail to conform to the entire wound bed. As a result, these products leave dead
spaces where bacteria and bioﬁlms can persist, compromising wound healing and increasing the
risk of infection. The proposed G4B membrane conforms closely to the wound bed, ensuring full
coverage and leaving no dead space where bacteria and bioﬁlms could persist. G4B is a self-
assembled peptide matrix membrane with preliminary and published data showing: i) antimicrobial
activity against a broad spectrum of MDROs34–38, including prevention and treatment of bioﬁlms; ii)
scaffolding properties for promoting cell attachment and proliferation in wounds, and iii) a durable
but ﬂexible and highly wound conforming membrane format. To prepare G4B for FDA-enabling
studies, we propose to: Aim 1) optimize G4B formulations based on physician user feedback,
mechanical properties, and conﬁrmatory antibioﬁlm and cytocompatibility testing, Aim 2) conduct
in vivo testing of SA1 formulations to conﬁrm G4B safety and efficacy, Aim 3) demonstrate the
feasibility of manufacturing G4B, including sterile packaging, and Aim 4) hold a Pre-Submission
meeting with the FDA to validate the planned 510(k) regulatory strategy. Gel4Med has a strong track
record of turning NIH investment into patient outcomes, securing FDA clearance through our
development of our ﬁrst product, G4Derm, that also utilizes peptide biomaterials to improve wound
care. With Phase II SBIR funds, Gel4Med will develop a membrane-based, antibioﬁlm product to
improve healing and limb preservation for chronic wound patients. Following the successful
completion of the proposed work, G4B will be ready for FDA-enabling GLP studies and a 510(k)
submission.

Public health relevance
Project Narrative The persistent bacterial infections, including biofilms, that plague chronic wounds are a main contributor to delayed healing and complications including limb amputation. The goal of this Phase II SBIR proposal is to develop a wound treatment membrane that addresses bacterial infections simultaneously with supporting tissue regeneration with a novel, peptide-based biomaterial. This product additionally improves the treatment of wounds by fully conforming to the wound bed, therefore achieving full coverage treatment of all areas of bacterial colonization.